A2CPS Genetic Variant Core

GENETIC VARIANT CORE
SUMMARY
Chronic pain is a complex problem, likely influenced by multiple environmental and genetic factors. Growing
evidence for a genetic basis for developing chronic pain suggests it may be possible to use genetic predictors to
differentiate between patients likely to be susceptible versus resilient to the development of chronic pain. This
project is the Genetic Variant Core (GVC) of the Omics Data Generation Center (ODGC) for the Acute to Chronic
Pain Signatures (A2CPS) Program. In this Program, the Clinical Centers will recruit and collect clinical data and
biofluid samples from two longitudinal cohorts of 1800 subjects each. Biofluid samples will be collected 0, 3, and
6 months after an acute pain episode, consisting of a specific surgical procedure or a specific musculoskeletal
trauma. These samples will be used to generate multi-omic data to validate 40 primary outcome biomarkers
indicating susceptibility or resilience to development of chronic pain, as well as to identify new candidate
biomarkers. For the proposed Genetic Variant Core, Aim 1, which will be executed in Year 1, will involve close
collaboration with other components of the A2CPS Program to establish the final study design and protocols. All
of the A2CPS Program investigators will work together to establish the 40 primary outcome biomarkers. The
ODGC and Clinical Center investigators will jointly decide on the specific sample type(s) and
collection/processing/storage methods. The ODGC and Data integration Resource Center/Data Coordination
Component (DIRC/DCC) investigators will establish Metadata and Data Standards and a workflow for
submission of metadata and data to the DCC. The GVC and the Administrative Core of the ODGC will establish
an integrated LIMS for sample and data tracking, and recording of metadata. The GVC and DIRC/Data
Integration and Analysis Component (DIAC) will establish data analysis pipelines. Aims 2 and 3 will span Years
2-4, with Aim 2 focused on DNA isolation and genetic variant arrays for the 3600 participant samples that will be
collected by the Clinical Centers. Aim 3 will encompass submission of metadata and data to the DIRC/DCC,
quality control of the data, and data analysis and interpretation. The primary goal of this Component is generation
and submission of high-quality gene variant array data for the validation of pre-selected genetic variant
biomarkers. While the study is not powered to identify novel genetic associations, we expect to extend the
analysis beyond the jointly selected genetic variant biomarkers to include additional variants implicated in
susceptibility/resilience to chronic pain. GVC component investigators will participate in integrative analyses with
the DIRC/DIAC aimed at developing pain signatures comprised of multiple biomarker types (including molecular,
clinical, psychosocial, and/or imaging biomarkers) indicating susceptibility/resilience to chronic pain, which can
be used to develop personalized strategies for prevention and treatment of chronic pain. The personnel for this
proposed GVC have acquired the necessary skills and knowledge to successfully execute this project from
participation in multiple large-scale projects generating genetic variant array data.